The Architectures and Underpinnings of Adaptive Evolution and Reproductive Isolation

1 Summary: Architectures and Underpinnings of Adaptive Evolution and Reproductive Isolation
2 This research program informs foundational yet unresolved questions at the interface between genomic
3 diversity and evolutionary process. It focuses on two research themes: (1) Connecting Genomic Diversity
4 to Adaptive Evolution, and (2) Genetic Windows Into Early and Late Stage Reproductive Isolation.
5 This research fuses ambitious but cost-effective Drosophila experiments with novel approaches to the
6 analysis of large data sets. D. melanogaster offers key advantages for this work. The global expansion of this
7 species has given rise to adaptive trait differences, and early stage reproductive isolation, between populations
8 that diverged in the last ~13,000 years. The experimental efficiency of Drosophila, along with its compact and
9 well-annotated genome, and its wealth of genetic resources and transgenic tools, combine to allow these
10 evolutionary phenomena to be studied in ways that might not be practical in any other animal system.
11 This research will focus on Connecting Genomic Diversity to Adaptive Evolution in two major respects.
12 Following up on recent studies of the genetic architecture of adaptive trait evolution which showed that
13 causative variants consistently remain polymorphic, the proposed research will develop and apply population
14 genomic resources for performing genotype-phenotype association testing to identify underlying genes and
15 candidate variants within previously identified trait-associated genomic regions. Secondly, this research will
16 investigate how molecular regulatory traits provide a bridge between genomes and adaptive changes. Diverse
17 regulatory traits at chromatin, RNA, and protein levels will be assayed from the brains of flies from tropical and
18 temperate origins, and analyzed via an improved evolutionary framework. For the first time, the types of
19 regulatory traits that most frequently show the influence of adaptive evolution will be revealed.
20 The proposed work will also leverage this system to look through Genetic Windows Into Early and Late
21 Stage Reproductive Isolation. Research will build upon recent evidence of hybrid breakdown in male fertility
22 among the offspring of crosses between African and European D. melanogaster populations. By genetically
23 mapping incompatibilities using a novel framework, illuminating their biology, and identifying and testing
24 potential causative genes, this research will offer a very rare genetic perspective on the very earliest stages of
25 reproductive isolation. In contrast, D. melanogaster and D. simulans are commonly viewed as fully isolated
26 species. And yet, new population genetic results reject a simple isolation history for these taxa. Research will
27 test whether ancient genetic structure or else recent or ancient introgression best explains these observations.
28 Collectively, this research is highly consequential for fundamental evolutionary genetics. It also holds
29 substantial health relevance in terms of understanding how evolution is likely to proceed in biomedically
30 important insects such as disease vectors, and by informing the genetics human trait variation and infertility.

Public health relevance
Narrative This research addresses the genetic foundations of how traits evolve and how populations begin to become reproductively isolated, while building upon and reinforcing scientific investment in the Drosophila model system. Its examination of how populations adapt to local environments will inform the underpinnings of human trait variation (with relevance to many diseases), while also clarifying how biomedically important insects are likely to evolve. Its focus on genetic incompatibilities may inform the causes of miscarriage and couple infertility, and the health consequences of Neanderthal genetic variants.